Deciphering the neural mechanisms of music processing in the developing brain: A multi-feature and multi-cultural comparison

Project Summary
Music training has long been used as a treatment to enhance neural function and behavioral outcomes
in clinical populations. There is an extensive literature describing how music-training and tonal language
learning alters the brain and behavior in healthy adult populations. One important unresolved issue is how
music experience and language experience interact in the developing brain.
Understanding how and to what extent music and language experience modulate cortical dynamics for
brain functions (e.g., music and speech processing) will open a crucial door to treat a myriad of neurological
conditions with an auditory or language base. The long-term overarching goal of this project is to uncover the
causal relationship between brain networks and behavioral aspects of music sensitivity in the developing brain.
This first project proposes to apply a combination of a music neurophysiological paradigm, a lexical tone
neurophysiological paradigm and behavioral measures to uncover the complex interaction between music and
lexical tone processing in the developing brain.
The three specific aims are: 1) To determine the cortical maturational trajectories of auditory processing
in terms of six main music features (rhythm, intensity, location, slide, pitch, and timbre) in 5-10 year old
children. Event-related potential (ERP) responses will be compared across age groups. A multi-feature music
oddball paradigm that includes six types of feature changes will be used. Significance: This aim is essential
for examining brain developmental plasticity for the processing of different music features. 2) To determine
whether early music training, tonal language, bilingual language experience and different English dialects
modulate cortical sensitivity to the above-mentioned six main music features. The ERP responses will be
compared across monolingual-bilingual, tonal-nontonal language, mainstream American English dialect –
African American English dialect groups (monolingual English with mainstream American English dialect with
and without music training, monolingual English with African American English dialect, bilingual Spanish-
English and bilingual Mandarin-English). Significance: These comparisons are important because it will, for
the first time, reveal the intricate relationship between dialectal experience, lexical tone development, bilingual
development and brain development for music processing at the cortical level. 3) To determine whether, and to
what extent, early music experience and language experience modulate cortical sensitivity to lexical tone
processing. The ERP responses to lexical tone contrast will be compared across the above-mentioned groups
of children. Significance: These comparisons are important because it will shed light on the relationship
between early music training and the neural representations for speech processing.

Public health relevance
Project Narrative Early music and language experiences produce structural and functional changes in the brain, however, the impact of such experiences, especially the interaction of the two has not been fully explored in children. The proposed research uses the combination of a music neurophysiological paradigm and a lexical tone neurophysiological paradigm to examine the influence of early music training, early tonal versus non-tonal bilingual acquisition and dialect experience on different aspects of music feature processing, as well as to determine the complex interaction between music training and language acquisition on the neural network for music and speech processing. Findings may lead to the development of new approaches that utilize music to treat developmental language disorder and neurological disorders.